CVM Vet-LIRN Veterinary DiagnosticLaboratory Program (U18) Clinical TrialsNot Allowed

PROJECT SUMMARY
Colorado State University Veterinary Diagnostic Laboratory Participation in the
FDA Veterinary Laboratory Investigation and Response Network
Project Director: Kristy Pabilonia Institution: Colorado State University
Co-Project Director: Josh Daniels Institution: Colorado State University
Co-Investigator: Gary Mason Institution: Colorado State University
The Colorado State University Veterinary Diagnostic Laboratory (CSUVDL) is accredited by the
American Association of Veterinary Laboratory Diagnosticians (AAVLD) as a full-service, all species
laboratory. The CSUVDL has a robust Quality System that meets and in most places, exceeds,
AAVLD guidelines, which are based on ISO17025 standards. The CSUVDL has strong capabilities
for veterinary diagnostic service regionally, nationally and internationally and performs more than
500,000 tests per year. The CSUVDL currently serves as a Tier 1 Laboratory for the United States
Department of Agriculture (USDA) National Animal Health Laboratory Network (NAHLN) and as a
Sentinel Laboratory for the Centers for Disease Control and Prevention (CDC) Laboratory Response
Network (LRN). Colorado State University maintains CDC/USDA Select Agent Registration, which
includes the Veterinary Diagnostic Laboratory Biosafety Level 3 facility.
The CSUVDL is well poised to serve as an active member of the Food and Drug Administration
(FDA) Veterinary Laboratory Investigation and Response Network (Vet-LIRN) program. The
CSUVDL can provide full veterinary diagnostic testing services, including bacteriology, chemistry,
toxicology, virology, parasitology and pathology testing and results interpretation. The CSUVDL is
housed in a new, state-of-the-art building with more than 20,000 square feet of laboratory space,
including a large necropsy floor, numerous BSL-2 laboratories and a 2,000 square foot USDA/CDC
Select Agent approved BSL-3 laboratory. The faculty and staff of the CSUVDL are well trained to
analyze veterinary cases and diagnostic samples using more than 250 diagnostic tests offered by our
laboratory. In addition, the CSUVDL has an advanced information technology system, including an
advanced Laboratory Information Managements System with the capabilities for sending HL7
messages. The CSUVDL routinely contributes to outreach and service activities for animal owners,
livestock producers and government agencies. Since its acceptance into the Vet-LIRN in 2011, the
CSUVDL has been active in all aspects of Vet-LIRN program, including participation in diagnostic
investigations, participation in proficiency tests and attendance at meetings. For this project, the
CSUVDL agrees to continue these activities and assist the Vet-LIRN with animal food and drug
emergency outbreak testing, provide surge capacities for testing and use standardized Vet-LIRN
methodologies.

Public health relevance
PROJECT NARATIVE Colorado State University Veterinary Diagnostic Laboratory Participation in the FDA Veterinary Laboratory Investigation and Response Network The Colorado State University Veterinary Diagnostic Laboratory is a state of the art, high-capacity diagnostic laboratory that has the capability of fulfilling the goals of the Vet-LIRN program. The CSUVDL can provide full veterinary diagnostic testing services for the Vet-LIRN program and will work with the program to investigate cases and contribute to the overall mission of the program.